1/2 percutaneous intervention versus observational trial of arterial ductus in lower gestational age infants (PIVOTAL)

PROJECT SUMMARY/ABSTRACT
Patent ductus arteriosus (PDA), the most common cardiovascular condition in preterm infants, is associated with
mortality and harmful longer-term outcomes including chronic lung disease (CLD) and brain injury. Although
treatment does not benefit all infants with PDA, likely due to spontaneous closure, treatment of some infants with
symptomatic PDA is necessary. Medications are often used to close persistent preterm PDA in the initial four
weeks postnatal, but fail to close the PDA in 1/3 of infants, in whom an intervention is the only remaining definitive
closure option (failed pharmacological management). A treatment dilemma exists in the first postnatal month for
the subset of infants with persistent, hemodynamically significant, and clinically symptomatic PDA (HSPDA) after
postnatal week one following failed pharmacological management. Invasive, intrathoracic PDA surgery was tra-
ditionally employed for infants with HSPDA, but associations between surgery and adverse neurodevelopment
prompted widespread adoption of non-interventional, supportive treatment. This watchful-waiting approach
avoids or delays procedure-related complications, but prolongs developing brain and lung exposure to PDA-
related hemodynamics. Evidence is emerging that duration of HSPDA exposure is an important predictor of CLD
and/or death. Percutaneous catheter-based closure (PPC) is a novel, minimally-invasive means of closing a
HSPDA. A duct occluder (ADO-II AS) was recently approved (1/2019) by the US FDA for preterm infants weigh-
ing ≥700 grams. However, the effectiveness of PPC in improving important neonatal outcomes relative to sup-
portive (non-intervention) HSPDA management has never been evaluated via a randomized trial (RCT). The
uncertainty is whether PPC should be performed early (days 7-30 postnatal) for all infants with HSDPA to prevent
PDA-related complications or only rarely as a last resort following a prolonged trial of supportive management.
The objective in this application is to determine if PPC improves cardiopulmonary and neurodevelopmental out-
comes via a multicenter RCT comparing the two strategies. Aim 1 will determine the effect of PPC versus sup-
portive treatment on ventilator-free days (VFDs) at 30 days post-randomization (non-survivors will be scored as
having zero VFDs). Aim 2 will determine the effect of PPC versus supportive treatment on secondary cardiopul-
monary, safety and neurodevelopmental outcomes. Aim 3 will evaluate whether neurodevelopment at 3-4
months corrected age is mediated by improved neurodevelopmental profiles at 34-36 weeks postmenstrual age.
Aim 4 will evaluate potential effect modifiers of HDPSA (e.g., sex, race/ethnicity, gestational age, age at ran-
domization) on VFDs and secondary outcomes. This trial will immediately advance the care of extremely preterm
infants with HSPDA following failed medical management by identifying whether PPC or supportive treatment
better improves cardiopulmonary and neurodevelopmental outcomes.

Public health relevance
Project Narrative As preterm infant survival continues to improve, uncertainty regarding the best treatment for hemodynamically significant patent ductus arteriosus (HSPDA) can have serious public health implications for this vulnerable population. A novel, US Food and Drug Administration approved duct occluder (ADO-II AS) now offers clinicians a minimally invasive option for closing HSPDA, but its effectiveness in improving important patient outcomes, relative to supportive, non-interventional HSPDA management, is unknown. This project is relevant to NIH’s mission to understand the processes of human growth and development by determining via a multicenter randomized trial, whether percutaneous HSPDA closure using ADO-II AS improves cardiopulmonary and neurodevelopmental outcomes as compared to supportive, non-invasive therapy.